Keratin and filament cell-cell junction cooperation in developmental and tumorigenic fate decisions

Carcinomas represent the majority of cancers diagnosed in the United States
each year, including a yearly estimated 3-5 million cases of nonmelanoma skin cancer and 1 million cases of
breast, lung, colon, and genital tract cancers. While these cancers originate in numerous organs, all carcinomas
are tumors arising from epithelia. Epithelia are a tissue type characterized by sheets of polarized cells tightly
attached to one another by cytoskeleton-linked cell-cell junctions, which form selectively permeable barriers.
Epithelia are also characterized by their expression of cytoskeletal filament-forming proteins called keratins.
Keratins are an expansive family of orthologous proteins exhibiting distinct biochemical properties in addition to
their highly conserved intermediate filament-forming domains. Importantly, keratins are a determining feature of
epithelial identity, and the alteration to keratin expression is a hallmark of carcinomas. While epithelia are
specified during development, they undergo a continuous regenerative process throughout life known as
homeostasis. Epithelial homeostasis is regulated by numerous signaling pathways which regulate cell
proliferation, migration, and differentiation in developing organs and can lead to tumorigenesis when
dysregulated. In the context of complex epithelial homeostasis, keratin proteins with distinct biochemical
properties and transcriptional regulation were shown to cooperate to affect the localization of the pro-growth
transcriptional co-activator YAP1 and regulate homeostatic cell fate decisions (cell division, differentiation,
death). Here, we aim to further define the mechanism of keratin-dependent regulation of cell fate decisions by
1) investigating the keratin regulation of pro-growth fate decisions during embryogenesis and development, prior
to the establishment of homeostasis, using a Xenopus laevis embryo model, and 2) testing this developmental
mechanism in the context of cell fate decisions during cancer initiation using a Xenopus laevis tumor model. To
define this mechanism, we will contextualize the keratin filament network within the broader epithelial
cytoskeleton by investigating the cooperation between the keratin and actomyosin filament networks at cell-cell
junctions, specifically (keratin-linked) desmosomes and (actin-linked) adherens junctions. This project
conceptualizes the keratin filament network as a spring whose ability to store mechanical energy is proportional
to its stiffness, which is determined by the post-translational modifications of its constituent keratin proteins. We
seek to define how the stiffness of the keratin filament network regulates the transduction of mechanical
information to transcriptional effectors of cell fate, including YAP1, through the cooperation with the
mechanosensitive actomyosin network, desmosomes, and adherens junctions. Overall, this project seeks to
determine a fundamental mechanism that regulates cell division and differentiation in epithelia that may be
perturbed during cancer initiation. Through the elucidation of the mechanism, we aim to uncover a fundamental
aspect of carcinogenesis, potentially informing the development of new and more effective prophylactics.

Public health relevance
Cancers arising from epithelial tissues, including skin, breast, lung, and colon cancers, represent the majority of the cancer burden in the United States. Epithelial cells are normally able to constrain cancer formation - despite continuously regenerating throughout life - by sensing the mechanical properties of the surrounding cells and connective tissue. This project aims to determine a fundamental aspect of how epithelial cells sense mechanical forces to balance cell division and tissue specification to better understand how epithelial cancers form.